The role of mitochondrial fission in beta cell function

Project Summary/Abstract
Nearly 10% of the world has diabetes and this number is projected to increase. Type 2 diabetes occurs when
beta cells fail to produce sufficient insulin in the face of insulin resistance. One important aspect of beta cell
failure is mitochondrial dysfunction. While mitochondrial have long been known to be critical for glucose
stimulated insulin secretion, it is now clear that mitochondria are not simply static metabolic organelles. They
are in a constant state of fission and fusion and disruption of this balance affects bioenergetics, mitophagy and
cell survival. We propose that mitochondrial morphology could be a novel target for diabetes therapeutics.
However, very little is known about how changes in mitochondrial morphology affect beta cell function and
survival in vivo. The central objectives of this proposal are to understand how loss of mitochondrial fission
affects insulin secretion, beta cell survival and mitophagy. Our specific aims are as follows. Aim 1: Define how
mitochondrial fission regulates the metabolic amplifying pathway of insulin secretion. Based on our preliminary
data, we hypothesize that mitochondrial fission is required for the NADPH amplifying pathway. We will use
optical reporters to ascertain the oscillatory dynamics of NADPH in response to glucose in the setting of acute
and chronic Drp1 knockout. Since Drp1 has roles outside of mitochondrial fission, we will use CRISPR
interference to silence a pure regulator of mitochondrial fission, Mief1, for comparison with the Drp1 knockout.
Finally, we will restore mitochondrial morphology in Drp1 deficient beta cells with concomitant knockdown of
the mitochondrial fusion regulator mitofusin-2 (Mfn2) to rescue insulin secretion. Aim 2: Determine the role of
mitochondrial fission in beta cell survival and mitochondrial quality control. In non-beta cells, mitochondrial
fission is thought to be important for mitophagy but be required for apoptosis. Based on our preliminary data,
we hypothesize that loss of Drp1 in the beta cell may protect cells from apoptosis but maytrigger mitophagy
and mitochondrial quality control. Aim 3: Establish the relevance of Drp1 in human islets with and without type
2 diabetes. We will knockdown Drp1 in primary human beta cells from non-diabetic patients and measure their
oxygen consumption, insulin secretion, and calcium dynamics. To test a role of mitochondrial dynamics in type
2 diabetes pathogenesis, we will measure levels of mitochondrial dynamics proteins in beta cells from type 2
diabetes patients and examine the mitochondrial morphology in these cells. Finally, to test a role of Drp1
downregulation in type 2 diabetes, we will re-express Drp1 in human diabetic beta cells and ask if glucose
stimulated insulin secretion can be improved. These studies will lay the foundation for future diabetes
therapeutics based on improving mitochondrial dynamics.

Public health relevance
Project Narrative Type 2 diabetes is reaching pandemic status and new treatments are needed that will change disease progression. The mitochondria of the pancreatic beta cell become dysfunctional in type 2 diabetes and we propose that understanding how mitochondria normally contribute to pancreatic beta cell function and survival will reveal new type 2 diabetes therapeutic targets. In this grant, we will explore the role of mitochondrial fission in insulin secretion and beta cell survival in human and mouse models.